Regulation of APOBEC3 cytidine deaminase-induced mutation during cancerdevelopment

Abstract
APOBEC signature mutations (C to T and C to G substitutions in TCA and TCT trinucleotide
sequences) comprise the second most abundant mutation signature in human cancers. This signature is
caused by aberrant activity of several members of the APOBEC family of cytidine deaminases, which normally
function in many cellular processes including the restriction of viruses. Recently, we found that APOBEC3A
(A3A) expression is elevated in APOBEC-mutated breast cancer cell lines, resulting in increased cellular
cytidine deaminase activity and breast cancer mutagenesis. The objectives of this proposal are to characterize
newly identified components of the APOBEC mutation signature, determine how A3A mRNA expression is
upregulated in cancer, define proteasomal controls on A3A protein abundance, and characterize DNA repair
pathways that limit A3A mutagenesis. Aim1 will determine the causes and consequences of A3A- and
APOBEC3B-induced insertion/deletion mutations. Aim 2 will characterize the mechanisms leading to aberrant
up-regulation of A3A in breast cancers by identifying the transcription factors and signaling pathways
responsible for increasing A3A expression. Additionally, we will investigate the mechanism(s) leading to
proteasome-dependent degradation of A3A and assess the mutagenic consequences of defective post-
translational control of A3A abundance. Aim3 will characterize anti-mutagenic roles of the homologous
recombination proteins BRCA1 and BRCA2 in template switch-mediated bypass of A3A-dependent abasic
sites at replication forks. We will determine whether BRCA1 or BRCA2-deficiency elevates APOBEC-induced
mutation in human cell lines and genetically define additional proteins involved in the pathway. Successful
completion of these aims will enhance our understanding of A3A regulation and its role in cancer etiology.
Additionally, these efforts will identify means to limit APOBEC-induced mutagenesis, which could provide
therapeutic benefit by limiting continued tumor evolution that leads to drug resistance.

Public health relevance
Project Narrative: APOBEC family cytidine deaminases are the cause of the second-most abundant type of mutation during cancer development. We recently identified APOBEC3A and APOBEC3B as, respectively, the primary and secondary sources of cytidine deaminase activity in breast cancer. This proposal investigates these enzymes' surprising ability to induce insertion/deletion mutations as well as how APOBEC3A-induced mutation is regulated through transcriptional activation, proteasomal degradation, and DNA repair mechanisms.